Data Analysis Core

ABSTRACT: Data Analysis Core
In our investigation of the cellular architecture of bowel tissue, we will continue to generate
multimodal single-cell resolution data. Using the Chromium Multiome platform, we generate
simultaneous single-nuclei RNA+ATAC-seq to profile the gene transcription and regulatory
programs of cells. We have defined previously-described cell populations as well as novel cell
types and sub-types. Our spatial data will be mapped through two highly multiplexed assays:
the CODEX immunoassay and the Molecular Cartography FISH assay. Because CODEX
throughput can be scaled, we will use it to map serial sections that will be reconstructed to make
three-dimensional maps. Molecular Cartography will provide a complementary transcriptome
map to enable more accurate integration of the single-nuclei data to the CODEX maps. We
have existing standardized pipelines to process each of these data types. We also have tools to
integrate these multi-modal data types. We will continue to refine these integrative methods as
we investigate our proposed organ of focus along with other organs in coordination with
HuBMAP. All of our data will be submitted to the HIVE and public repositories for broad access
to the community.